PHARMACOKINETICS OF METABOLIC PROBES IN PATIENTS WITH RENAL INSUFFICIENCY

Determine the effects of renal insufficiency on drug metabolism by investigating specific metabolic pathways using the 'Pittsburgh' five drug cocktail of caffeine, debrisoquine, mephenytoin, chlorzoxazone, and dapsone; alterations in fractional metabolic clearance of specific metabolic pathways will enable investigators to determine the usefulness of metabolic cocktails in patients with renal disease.